Mechanistic human studies to prevent Hirschsprung-associated enterocolitis

Project Summary: Our goal is to find new ways to prevent and treat Hirschsprung disease-associated
enterocolitis (HAEC), a form of bowel inflammation. HAEC is a life-threatening manifestation of Hirschsprung
disease (HSCR) characterized by explosive (often bloody) diarrhea, abdominal distension, fever, and risk of
bacterial translocation from the gut lumen to the blood, causing sepsis. Sepsis is the most common cause of
death in children with HSCR. HSCR is a first trimester developmental anomaly defined by absence of enteric
nervous system (ENS) at the end of the bowel. Bowel lacking ENS is called “aganglionic”. Aganglionic bowel
tonically contracts and lacks propagating contractions causing functional obstruction. Because ENS also
controls blood flow, epithelial, and immune cell activity in the bowel, HAEC mechanisms are complicated, and
incompletely understood. HSCR treatment (devised 75 years ago) is surgical removal of aganglionic bowel and
re-attachment of “good” ENS-containing bowel near the anal verge (called “pull-through surgery”). In theory,
pull-through surgery should result in a perfect cure, but ~35% of children have HAEC after surgery and ~10%
undergo “re-do” surgery because of persistent problems. If we understood why some children with HSCR
appear healthy after pull-through surgery and others have recurrent HAEC, we might then be able to
devise new ways to treat or prevent HAEC. Interestingly, HSCR symptoms vary dramatically before any
treatment. Some children are critically ill within days of birth. Others appear well for months or years before
HSCR symptoms become clear. For example, recently a 53-year-old man was newly diagnosed with HSCR in
Japan. Because HSCR is always present at birth, variable symptom onset and severity suggests HSCR
symptoms (including HAEC) are influenced by factors beyond ENS biology. Serendipitously, we discovered
in an inbred HSCR mouse model (Piebald lethal, sl/sl) that diet alters survival 3.4-fold within a single
mouse colony. Exploiting this observation, we discovered the “Protective” diet reduces Enterobacteriaceae
(bowel inflammation-associated bacteria), increases stool butyrate (energy source for colonocytes and a
histone deacetylate inhibitor), increases epithelial production of anti-microbial peptides and fucosyltransferases
(which protect from inflammation), and reduces gut epithelial oxygen levels (facilitating growth of beneficial
obligate anaerobes near colon epithelium). These mechanistic observations suggest new therapies (e.g.,
butyrate supplementation or elimination of Enterobacteriaceae), but we need to know which mechanisms in
mice are relevant for humans with HSCR. To do this we will analyze stool metabolites, stool microbes, and gut
epithelial biology in bowel removed from children during pull-through surgery (Aims 1 and 2). We will also
examine ENS anatomy near the proximal resection margin using a new tissue clearing and 3D imaging method
we invented that provides exceptional data about ENS anatomy (Aim 3). Our studies test specific mechanistic
hypotheses and may suggest potentially effective HAEC prevention or treatment strategies.

Public health relevance
Project Narrative: Hirschsprung disease, a life-threatening birth defect where the enteric nervous system (ENS) is absent at the end of the bowel, predisposes to bowel inflammation (enterocolitis) and death from sepsis. In a Hirschsprung disease mouse model, we found that a Protective diet extends survival 3.4-fold and identified several inter- related mechanisms that we hypothesize underlie diet-induced changes in survival. Here we take advantage of mechanistic insight from the mouse model, and a new tissue clearing and imaging method we invented, to identify risk factors for enterocolitis in human children that could be manipulated to prevent bowel inflammation and sepsis.